Human CD8+ T Cell Tolerance by Nondepleting Humanized CD8-Specific Antibody

? DESCRIPTION (provided by applicant): Antibody (Ab)-based mmunotherapy has been used in the clinic to treat T cell-mediated pathologies including autoimmunity such as type 1 diabetes (T1D), allograft transplantation, and graft versus host disease (GVHD). Typically these Ab indiscriminately deplete T cells, which can lead to only short-term efficacy and complications related to immunosuppression. Application of nondepleting (ND) Ab offers an approach to modify pathogenic and regulatory T cells without systemic T cell loss. Indeed we recently reported that ND Ab specific for the CD4 and CD8α co-receptors reverses diabetes long-term in NOD mice. Despite the fact that all T cells are bound by the ND αCD4 and αCD8 Ab, induction and maintenance of tolerance are tissue-specific, and protective immunity is unaffected in treated NOD mice. To date, only ND Ab specific for human (hu) CD4 have been studied in a limited number of clinical trials for the treatment of autoimmunity. ND Ab specific for huCD8, however, have yet to be reported. It is very likely that combined ND αhuCD4 and αhuCD8 Ab therapy will be needed to effectively treat pathologies driven by both CD4+ and CD8+ T cells, such as T1D. With this in mind we recently established ND Ab specific for huCD8α. Immunoglobulin VL and VH gene segments derived from cDNA encoding huCD8α-specific murine IgG? were used to engineer αhuCD8α human IgG4 recombinants. Notably, IgG4 exhibits limited proinflammatory effector and depleting function. The objective of this R21 is to test the tolerogenic function of ND αhuCD8α IgG4. Humanized mouse models are being employed to study the immunoregulatory effects of αhuCD8α IgG4 in vivo in xenogeneic GVHD-mediated pancreatitis and human islet allograft rejection. In Aim 1, experiments will focus on defining mechanisms of tolerance induced by ND αhuCD8α IgG4 in the suppression of pancreatitis that develops in humanized mice. Aim 2 will investigate the tissue-specificity and therapeutic efficacy of ND αhuCD8α IgG4 in blocking human islet allograft rejection in humanized mice. Together these experiments will establish the tolerogenic properties and translational potential of ND αhuCD8α IgG4, as well as provide novel reagents to treat T cell-mediated autoimmunity and other pathologies in the clinic.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this work is to define the tolerogenic properties of novel nondepleting, humanized antibodies specific for the human T cell co-receptor CD8. New insight will be gained into the tolerogenic properties and translational potential of these antibodies through experiments employing humanized mouse and human islet allograft models. If shown to be effective, the nondepleting humanized anti-human CD8 antibodies can be directly tested in future clinical studies to suppress T cell-mediated autoimmunity such as type 1 diabetes, and other T cell driven pathologies.